Improving the analysis and use of contaminated immunoassays: from methods development to implementation

PROJECT SUMMARY
Immunoassays – tests that estimate the concentration of analytes in a sample using antibody-antigen binding
reactions – are widely used for clinical diagnostics, biopharmaceutical analysis, and environmental monitoring.
The current method for estimating concentrations of analytes measured in immunoassays has several limitations,
including large measurement errors, difficulty in estimating very low or high concentrations, and noisy estimation.
In addition, with the advance of new technologies using multiplex assays, multiple analytes can be measured
simultaneously in a single plate, but the current method fails to account for the potential correlations between
multiple analytes of the same sample. Further, operator error may arise and environmental samples can be
contaminated, resulting in assay errors. Although some Bayesian methods exist that use immunoassay data more
efficiently, they have not yet been incorporated into a practical workflow, in part because of concerns about
robustness to model error. Motivated by these challenges, the proposed research aims to develop a new Bayesian
workflow for the analysis of immunoassay data, considering possible error and contamination in the samples and
providing a step-by-step guide to model building, checking, and validation. Further, to enhance the proper use
of immunoassay data, a joint modeling and a two-step model approach will be developed to analyze exposure-
outcome associations accounting for the uncertainty in the exposure measure by immunoassays. The methods will
be developed and validated using immunoassay data of indoor allergens with dust samples from the New York
City Neighborhood Asthma and Allergy Study. A lab protocol and a graphical user interface will be developed
and tested to facilitate the uptake of the proposed methods. Once completed, the proposed research will provide
methods and tools for the analysis and use of potential contaminated immunoassay data, advance research in
the broader scientific field when dealing with model contamination and uncertainty in predictors, and provide
important insights into allergic sensitization and asthma morbidity among asthmatic children.

Public health relevance
PROJECT NARRATIVE The proposed research will develop new statistical methods for estimating concentrations of analytes measured in immunoassays, considering measurement error and contamination in the samples, and modeling exposure-outcome associations with adjustment for exposure measure uncertainty. The proposed new methods will be developed based on the indoor allergen measures collected using ELISAs and multiplex assays in the New York City Neighborhood Asthma and Allergy Study and will be used to assess the associations between concentrations of indoor allergens and asthma morbidity among asthmatic children. The methods and tools developed in this proposal will have a wide range of applications and can be used to improve lab analyses, which are crucial for diagnosis, treatment, and intervention decisions in many areas of medicine and public health.